Neural dynamics underlying brain state-dependent memory functions

Project Summary/Abstract
Mental health disorders associated with memory deficits have been on the rise for a few decades, highlighting
the need for understanding the brain mechanisms of memory from a systems neuroscience point of view. One
of the outstanding problems regarding the mechanisms of memory is how the brain can continuously
incorporate new memories while leaving recently acquired knowledge intact. The current accepted model sets
that recently acquired memories are reactivated in the hippocampus during sleep, an initial step for memory
consolidation, during sharp-wave ripples (SWRs), hippocampal oscillations important for memory and planning.
Yet, this process is concomitant with the hippocampal reactivation of prior memories, posing the problem of
how to prevent interference between older and recent, initially labile, memory traces. Theoretical work has
suggested that consolidating multiple memories while minimizing interference can be achieved by randomly
interleaving their reactivation. Alternatively, a temporal micro-structure that promotes the reactivation of
different types of memories during specific substates during the overall course of the sleep could exist. Indeed,
work in humans suggests that non-rapid eye (NREM) movement and rapid-eye movement (REM) states can
be further subdivided into substages that differently correlate with memory processes. To understand this, we
propose to simultaneously monitor memory reactivation (using electrophysiology) in combination with brain
states and substates (using pupillometry) in naturally sleeping mice after performing a hippocampal dependent
memory task. Our preliminary data show that we can successfully record pupillometry and electrophysiology in
naturally sleeping mice and distinguish both NREM and REM phases of sleep. Furthermore, our preliminary
data suggest that pupil fluctuations can reveal a previously unknown micro-structure of non-REM sleep and
associated memory processes, such as memory replay. Specifically, our preliminary data show that memory
replay of recent experiences dominated in sharp-wave ripples (SWRs) during contracted pupil substates of
non-REM sleep, while replay of prior memories preferentially occurred during dilated pupil substates. Initial
experiments show that closed-loop disruption of SWRs during contracted pupil non-REM sleep impaired the
recall of recent memories, while the same manipulation during dilated pupil substates had no behavioral effect.
We will investigate what are the underlying mechanisms of the distinct pupil associated memory processes
during NREM sleep. If successful, the results of this proposal will solve a long-standing question in traditional
neuroscience of learning and memory: how the brain can multiplex distinct cognitive processes during sleep to
facilitate continuous learning without interference. Applying the concept of isolating pupil-guided cognitive
substates to other domains (such as learning or attention) can offer novel insights into our current
understanding of cognition. Importantly, using this methodology during pathological conditions can inform
current diagnosis pipelines of different mental health conditions associated with memory deficits.

Public health relevance
Project Narrative Understanding the brain mechanisms of continuous learning, i.e., how the brain incorporates new memories without compromising existing knowledge, is key in neuroscience. In this project, I will leverage a novel combination of tools combining electrophysiology with pupillometry in naturally sleeping mice to investigate how hippocampal representations are integrated into memory but segregated from previously existing knowledge. Providing the link between neural processes of integration and segregation of memories and pupillometry can advance our understanding of mental health conditions and inform current diagnosis methodologies used in humans.